DISSECT ORGANIZATION OF SPINDLE POLE BODY USING FRET &DECONVOLUTION MICROSCOPY

A multiprocessor version of SEQUEST is being created to increase the throughput of database searching. The software is based on the parallel virtual machine architecture and divides the search equally among the computers. A linear increase in search time is expected for each additional processor used. The system is operational and is being optimized for speed.